BONE MARROW CRYOPRESERVATION AND AUTOLOGOUS TRANSPLANTATION IN LYMPHOMA

Toxicity to hematopoietic cells limits doses of cancer chemotherapy and radiation therapy. Recent advances permit cryopreservation of large numbers of viable hematopoietic stem cells. Some tumors show a dose-dependent response to drugs, suggesting that patients showing progressive disease while receiving cancer treatment could benefit from marrow-lethal doses of drugs or radiation followed by "rescue" with autologous cryopreserved cells.